Development of a Blood-based Diagnostic for Early Detection of Transthyretin Amyloidosis

ABSTRACT
Transthyretin amyloidosis (ATTR) is a rare, progressive, and ultimately fatal condition characterized by the
abnormal extracellular deposition of transthyretin (TTR) protein within the peripheral nerves (ATTR-PN) and/or
within the heart (ATTR-CM). There are two types of ATTR: (1) hereditary ATTR (hATTR), where the destabilizing
mutation in the TTR-gene is inherited, or (2) ATTRwt, in which people with the wild-type TTR-gene sequence
develop the disease sporadically. Recent estimates put the worldwide number of people affected by ATTR at
approximately 550,000. However, these patient populations are thought to be significantly underdiagnosed, as
there is a lack of rapid and readily available diagnostics.
New diagnostics for ATTR disease are needed as confirmation of ATTR is slow, taking up 5 years. Many patients
present with symptoms that can be attributed to other conditions, leading to misdiagnosis. Due to this, ATTR is
often diagnosed by process of elimination of other diseases and many patients have to see multiple specialists
before getting the correct diagnosis, causing a delay in treatment and further amyloid deposition. Given that the
life expectancy once diagnosed with ATTR is only 2-10 years, a blood-based diagnostic and biomarker could be
used to shift the current paradigm from confirmation of late-stage deposition to a clinical level screen, allowing
an individual with suspected risk to receive disease-modifying treatment earlier, reducing mortality, and
improving patient quality of life. Furthermore, a diagnostic biomarker will be invaluable in determining the efficacy
of drugs for treatments which have been shown to have variable long-terms outcomes for patients. This will allow
physicians to guide patients to the most cost effective and appropriate approved drug therapies for their
condition.
The path from normal TTR to amyloid deposition proceeds through a monomeric intermediate which can be a
biomarker of disease risk and progression. The proposed blood-based diagnostic is designed specifically to
detect the TTR monomer using novel, ultra-rare antibodies that have been discovered and will be rapid, sensitive,
and non-invasive. In Phase 1, initial proof-of-concept data will be generated to show that there is elevated TTR
monomers in patients diagnosed with ATTR compared to normal, healthy donors. If successful, this will be the
first step towards the commercialization of the first blood-based diagnostic for the disease.

Public health relevance
NARRATIVE Transthyretin Amyloidosis is a rare and fatal condition which is difficult to diagnose with limited, expensive, and only moderately-effective treatment options. We propose to develop an inexpensive and rapid diagnostic tool to be deployed as a part of clinical level medical screenings in order to diagnose this condition earlier, allowing for potentially improved treatment outlooks, and to monitor treatment status in diagnosed patients.